ACTG 398: AMPRENAVIR COMBINATION THERAPY FOR HIV INFECTED SUBJECTS

To investigate the efficacy and safety of combination antiretroviral therapy in HIV infected patients who have experienced virologic failure on one or more approved HIV protease inhibitors.